Evaluating METTL1-mediated m7G tRNA methylation as a novel dependency in alveolar rhadomyosarcoma

The oncogenic fusion protein PAX3/7-FOXO1 is the major driver of alveolar rhabdomyosarcoma (ARMS)
tumorigenesis but is challenging to therapeutically target. Current treatment options for patients with ARMS are
limited to cytotoxic chemotherapies. Identifying novel dependencies unique to the PAX3/7-FOXO1 fusion
protein may provide new targeted therapeutic avenues for treating ARMS. RNA modifications have garnered
recent interest as potential therapeutic targets due to their reversible nature. tRNA modifications, specifically
m7G, play direct roles in regulating translation and have been co-opted by oncogenic programs to selectively
promote the translation of oncogenic proteins. Our understanding of how m7G tRNA methylation contributes to
tumorigenesis is limited. The K00 phase of this proposal will profile the dynamic role of m7G tRNA methylation
in ARMS tumorigenesis and unveil novel insights into how this epitranscriptomic mechanism is dysregulated in
ARMS. Oncogenic transformation is a dynamic process and m7G tRNA methylation is similarly dynamic in
nature. We hypothesize that METTL1, an m7G methyltransferase, is a dependency in ARMS that promotes the
selective translation of ARMS-promoting proteins in an m7G-dependent manner. Elucidating the functional
relationship between PAX3/7-FOXO1 and METTL1 has yet to be identified but may serve as a previously
unidentified therapeutic avenue. We seek to evaluate this relationship and dependency in ARMS
tumorigenesis in two aims. In Aim 1, we seek to establish METTL1 as a therapeutic target in ARMS and
evaluate the relationship between METTL1 and PAX3/7-FOXO1 using both genetic and chemical approaches
in vitro and in vivo. In Aim 2, we will map the METTL1-dependent targets across ARMS tumorigenesis. Current
understanding postulates that the cell of origin for ARMS are myoblasts and that myoblasts can undergo
oncogenic reprogramming and transform into an ARMS cell. Therefore, we propose to map the changes in
METTL1-dependent m7G targets across the transformation continuum from a myoblast to an ARMS cell. We
hypothesize that the m7G-dependent targets change dynamically across the transformation from a myoblast to
an ARMS cell. Successful completion of the K00 phase of this proposal will uncover novel mechanisms of m7G
tRNA methylation and establish METTL1/m7G-dependent targets as potential therapeutic targets and
biomarkers of ARMS development. Our proposed work has significant translational implications and may
provide expanded insights into ARMS tumorigenesis and lead to the development of targeted treatment
options for patients with ARMS. Completion of the K00 phase of this proposal will allow me to develop critical
technical and project management skills necessary to establish myself as a competitive candidate for a
successful independent research career in cancer biology.

Public health relevance
Alveolar rhabdomyosarcoma (ARMS) is the most common childhood sarcoma and is driven by the PAX3/7-FOXO1 fusion protein. Therapeutically targeting the PAX3/7-FOXO1 fusion protein has proven challenging and there remains a critical need to identify new novel dependencies and targets that may prove as more effective therapeutic avenues. The K00 phase of this proposal will profile the METTL1-dependent changes in m7G tRNA methylation and establish METTL1 and/or its targets as potential therapeutic targets for the treatment of ARMS.